Perceived racism, cardiovascular disease risk, and neurocognitive aging: Diversity Supplement

Black Americans are twice as likely as White Americans to have Alzheimer’s disease (AD), independent of
genetic risk. Despite this knowledge, little is known about whether and how chronic experiences of racism
contribute to medial temporal hippocampal (MTH) and prefrontal-executive system integrity, systems that
exhibit profound neurodegeneration in AD and vulnerability to chronic stress. Although comorbid illnesses and
socioeconomic status contribute to the AD health disparity, disparities remain. This highlights a critical unmet
need for understanding social and societal stressors to disparities in brain health. A major contributor to health
inequities in the U.S. is chronic stress due to the cumulative effects of racism over the lifetime. The impact of
chronic interpersonal and institutional/structural racism, unique and salient forms of chronic stress in Black
Americans, on the neurocognitive integrity of these brain systems is not well understood. Since perceived
racism contributes to health disparities in cardiovascular disease (CVD) risk factors, which are also risk factors
for AD, perceived racism should have a significant impact also on the AD health disparity. The objective of the
parent R01 grant is to investigate the impact of racism on 1) CVD risk and 2) neurocognitive MTH-memory and
prefrontal-executive system integrity in Black seniors and to examine potentially underlying biological
mechanisms. The research objective of this diversity supplement is to examine the impact of consequences of
structural racism on neurocognitive integrity, namely 1) acculturation, a social compensatory mechanism
defined as the incorporation of the cultural norms of the social majority within a society, and 2) lower education
quality, leading to poorer dementia-related health literacy and greater public stigma associated with AD. The
central hypothesis of the parent R01 grant is that cognitively healthy Black seniors who have experienced
higher levels of chronic racism will show greater CVD risk and poorer MTH and prefrontal integrity than those
who have experienced fewer instances of racism over their lifetime. CVD risk and mental health may mediate
(i.e., explain) the relationship between racism burden and neurocognitive integrity. This diversity supplement
extends the parent grant by examining the relationships between AD-related health literacy, and public stigma
associated with AD with cognitive and neuroimaging outcomes (Aim 1) and acculturation (Aim 2) with cognitive
and neuroimaging outcomes. Aim 3 is exploratory and will examine racism burden and public stigma as
moderators of the relationship between acculturation and neurocognitive outcomes. The proposed diversity
supplement is for the candidate to gain expertise in how proxies of anti-Black structural racism affect brain
health in older Black self-identifying adults. To achieve these goals, in addition to the research aims outlined
above, the candidate is proposing training in multimodal neuroimaging (i.e., structural and fMRI) and statistical
modeling, and advancing mastery of MTH- and prefrontal-dependent functions related to anti-Black
racism. This supplement will set up the candidate for success in independent neurocognitive aging research.

Public health relevance
AWARDED PROJECT NARRATIVE Although Black Americans are twice as likely to have Alzheimer’s disease than White Americans, little is known about the impact of social and societal determinants of health on neurocognitive integrity of the medial temporal hippocampal memory and prefrontal-executive systems, the primary brain systems impacted in Alzheimer’s disease. The objective of this application is to investigate the impact of interpersonal and institutional/structural racism on neurocognitive integrity of these brain systems in Black adults aged 65 years and older and to examine cardiovascular disease risk as an underlying biological mechanism. Addressing this knowledge gap is critical for developing new health policies and biobehavioral and social interventions for healthy aging.